Pediatric Acute Respiratory distress syndrome MAnagement (PARMA)

PROJECT SUMMARY/ABSTRACT
Acute respiratory distress syndrome (ARDS) is characterized by acute onset of diffuse, bilateral pulmonary
edema and severe hypoxemia not fully explained by cardiac failure. ARDS affects nearly 45,000 children in the
United States annually, representing 10% of mechanically ventilated children in pediatric intensive care units
(PICUs), with an associated mortality rate of up to 20%. There are no specific pharmacological therapies for
ARDS, and supportive care remains the mainstay of treatment. In children, a lack of therapies is further
compounded by uncertainty in management, as guidelines are extrapolated from adult ARDS, with uncertain
applicability. However, pediatric ARDS possesses a distinct epidemiologic and outcome profile, necessitating
studies specific to this population. Lung-protective ventilation with lower tidal volumes and driving pressures
(defined as plateau pressure minus positive end-expiratory pressure) is the backbone of ventilation strategies
in adults, with variable adoption in pediatrics. However, pre-clinical and observational clinical data suggest that
the tidal volume and driving pressure limits extrapolated from adults are too restrictive for children. As lower
tidal volumes and driving pressures are associated with worse oxygenation and ventilation, overly restrictive
lung-protective ventilation may contribute to prolonged ventilation via worse gas exchange in pediatrics with no
improvement in outcomes. In a re-analysis of adult ARDS cohorts, our group demonstrated that driving
pressure is the most significant causal effector of mortality. By contrast, oxygenation (measured as PaO2/FIO2)
was primarily implicated in children. Unfortunately, observational studies are intrinsically confounded, as higher
tidal volumes and pressures are used in sicker children with greater baseline risk for poor outcomes.
Furthermore, as pediatrics uses different ventilator modes, plateau pressures are rarely measured and ΔP
(peak pressure minus positive end-expiratory pressure, a close approximate of driving pressure in pediatric
modes) is substituted. Thus, a randomized trial comparing specific ventilation strategies is sorely needed in
pediatric ARDS, with post-randomization ventilator protocols congruent with current pediatric practice. Herein
we propose the Pediatric ARDS MAnagement (PARMA) trial, a phase 2A trial of high versus low ΔP ventilation
in pediatric ARDS conducted at the Children’s Hospital of Philadelphia (CHOP). Additionally, we will use
electrical impedance tomography (EIT) to quantify lung aeration. Given the low prevalence of pediatric ARDS
and low mortality rates, PARMA will be analyzed in a Bayesian framework, utilizing a composite primary
outcome that combines time to hypoxemia resolution and mortality. We specifically will test the efficacy of a
high ΔP (25 cmH2O) versus low ΔP (15 cmH2O) ventilation on time to resolution of ARDS (alive and
PaO2/FIO2 > 300), hypothesizing faster hypoxemia resolution (Aim 1), and improved lung aeration (Aim 2) with
high ΔP. PARMA addresses a critical knowledge gap in pediatric mechanical ventilation, and will directly inform
the design of a subsequent definitive trial of different ΔP strategies in pediatric ARDS.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS) is common and deadly in children, and ventilator management is largely extrapolated from adults, with uncertain applicability. As pediatric ARDS has a distinct pathophysiology and epidemiology, ventilator strategies should explicitly be tested for efficacy in children. The proposed trial will specifically test the efficacy of two distinct ventilator strategies, thereby addressing a critical knowledge gap in pediatric mechanical ventilation, and directly informing the design of a larger future trial of ventilation strategies in pediatric ARDS.